The Impact of Federal COVID-19 Provider Relief Funds on Patients, Hospitals, and Disparities

Project Summary/Abstract
The outbreak of COVID-19 in 2020 imposed extreme demands on the US medical system. Congress
responded with $178 billion in emergency relief to be shared among hospitals, physicians, and other providers.
However, little is known about the impact of these funds on inpatient capacity, patient experience, patient
mortality, or closure and consolidation. The impact of funding on racial/ethnic disparities is also unknown. I
aim to address these gaps in knowledge.
I propose to exploit a natural experiment made possible by how the US Department of Health and Human
Services (HHS) distributed $34 billion in COVID-19 relief funds for hospitals. These funds, awarded to safety-
net hospitals and hospitals with high numbers of COVID-19 cases early in the pandemic, were allocated using
formulas with inflexible thresholds. Using regression discontinuity methods, I will compare outcomes at
hospitals barely missing the criteria for funding with hospitals barely surpassing the criteria for funding. I will
extend the common regression discontinuity design to accommodate the multi-variable, multi-cutoff formulas
adopted by HHS for fund allocation.
Results will have broad policy relevance in several respects, irrespective of whether I detect statistically
significant effects. Findings will speak to the advisability of channeling finite resource to the acute care system
when public health conditions next overwhelm capacity. Evaluation of this relationship between funding and
capacity will speak directly to AHRQ’s focus on improving safety, quality, and access. The research will
increase understanding of the trade-off between quality and affordability, which can in turn inform decisions
around cost containment. In addition, the research will contribute to understanding of the relationship between
hospital funding, hospital closures, and competition-reducing consolidation. Closures and consolidation
represent perennial challenge to access and affordability – areas of key focus for AHRQ. Finally, findings will
speak to the extent that politically viable, “color-blind” policies can reduce disparities across racial and ethnic
lines. In so doing, findings can inform the tactics used by policymakers and advocates to reduce healthcare
inequities

Public health relevance
Project Narrative The US Department of Health and Human Services has distributed more than $34 billion in COVID-19 relief to hard-hit hospitals. I will exploit binary funding cut-off criteria to evaluate the impact of relief on: (a) hospital- level capacity, staffing, and service delivery; (b) patient experience and mortality; (c) hospital markets; and (d) disparities across race and ethnicity. Findings will advance understanding of the relationship between resources and hospital quality, access, and cost containment – as well as the effectiveness of “color-blind” strategies in reducing disparities.